T32 Research Training in Diabetes and Endocrinology

7. PROJECT SUMMARY/ABSTRACT
This application is a competitive renewal of the training grant “Research Training in Diabetes and
Endocrinology,” which would represent years 47-51 of the first, and longest-running, T32 grant at the University
of Pittsburgh. The longevity is a testament to the success of the program in providing postdoctoral trainees with
the research/career skills necessary for developing independent academic careers. Over that time period, the
research landscape has changed dramatically, and this training program has adapted to complement the
changes. One notable and relatively recent change is the increased complexity of medical research, requiring
cross-discipline integration of research programs. This change necessitates that researchers operate in an
environment that provides a thorough grounding in the translational focus of medical research. Added to this is
the need for ever greater competency in the ancillary skills that are required to complement the core research
skills – including project, group, and multi-team collaboration management, grant writing, public presentations,
transitioning to independence, and others. Historically, these skills were often learned ‘on the fly’, but now
require a more structured approach. During the current cycle of the program we have worked assiduously to
implement such a program, which we believe has resulted in great success and outcomes. Thus, our trainees
are continuously immersed through hands-on-mentoring, peer-to-peer interactions, research experiences,
didactic classes, education workshops, and presentation opportunities in a truly integrated translational
research training program. At a practical level, this is reflected in (i) outstanding research opportunities that are
centered on three research hubs (basic, clinical, and public health/epidemiology); (ii) exceptional training
faculty with expertise in basic, clinical, and public health/epidemiology research; (iii) access to a range of
didactic courses, workshops, and educational experiences, including masters and certificate programs, that
buttress and complement research opportunities and, in many cases, emphasize translational themes; (iv)
structured career development courses that impart skills ranging from managing group projects to presentation
skills, through the T32-to-K-to-R grant transition; (v) a continuous assessment program for trainees, reinforced
by an Individual Career Development Plan, a 3-person mentoring team, and yearly progress evaluations by a
Training Committee that focuses on the individualized professional development of trainees; and (vi) program
management that oversees the ever-increasing complexity of research training in medical research, including
internal and external advisory boards. Our expectation over the next cycle of the training program is that we will
continue to train 4 postdoctoral fellows per year, with a mix of MDs and PhDs, and will offer two to three years
of support to each trainee. At the time of writing, 11 trainees have been supported by the training program in
the 2016-2021 cycle, and 8 have graduated (3 are still in training). Seven graduates applied for, or received,
competitive grant funding, 7 graduates remain active in research careers, and 3 obtained faculty positions.
Nineteen first author peer-reviewed publications were produced (43 total peer-reviewed publications), and 27
first author abstracts were presented at national scientific meetings. All 8 graduates published at least one first
author original research manuscript. Eighteen grants were submitted and 11 were funded. These metrics
represent concrete and categorical evidence of the continued success of our training program.

Public health relevance
8. PROJECT NARRATIVE This training grant contributes to the replenishment of specialists, both MD and PhD, in a number of topical areas of national health priorities. These include, but are not restricted to, diabetes, obesity, cardiovascular disease, women’s health, and behavioral medicine. It is a high quality and highly structured program, supported by an outstanding training faculty and exceptional institutional resources at one of the premier medical research campuses in the US. Over its long history (>46 years) it has been very successful in training outstanding fellows for research and research-related positions in academia and other research settings, as defined by the NIH.